Using mobile phones for social and behavioral sensing of mood disorder patients

DESCRIPTION (provided by applicant): Mood disorders are among the leading causes of morbidity and mortality worldwide, and have a profound impact on quality of life and productivity for millions of people. A longstanding barrier to progress, both in the context of clinical setting and drug trials has been the fundamental difficulty of accurately measuring mood states, behaviors, and social functioning of individuals affected by mood disorders. Mobile phones have become an integral part of modern life, and our prior work has shown that they can be used to collect behavioral and social network data at very large scales. Using existing open-source software as a foundation, we will develop a smartphone application that functions as a digital self-report instrument and simultaneously, in an unobtrusive manner, collects passive data on both the behavior and communication patterns of subjects. Two cohorts, a group of psychiatric outpatients and a non-psychiatric control group, will install the application on their own phones, which enables us to collect four longitudinal streams of data over a two-year period. First, we will collect active data consisting of subjects' responses to questions, presented by the smartphone application, about their mood and well-being. Second, we will utilize built-in accelerometer and GPS devices to collect passive mobility and location data. Third, we will track how subjects use other applications on their smartphones. Fourth, we will employ anonymized call and text messaging logs to learn about the structure and dynamics of the phone-mediated social network of subjects. The main objective of this proposal is to develop new analytical tools and technology capable of integrating these four streams of data in order to create a set of novel behavioral metrics. These metrics, validated for the outpatient cohort using quarterly clinical evaluations, will provide low- cost, highly scalable tools for monitoring social functioning and behavioral patterns of participants. Such tools could profoundly improve clinical management of psychiatric illnesses, and expedite the development of new efficacious treatments. The project is innovative in the way it combines longitudinal active and passive data streams, collected unobtrusively on the smartphone, to study behavioral changes caused by mood disorders. The resulting smartphone software platform and the requisite data analytic tools will be openly shared with the scientific community, and subsequent studies will be able to leverage this platform at no cost. The PI has a strong track record of innovative, high impact multidisciplinary work and has published scientific articles in journals such as Science, PNAS, and JAMA; his work has been covered in Nature, Science, BBC News, and the New York Times, among others.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT A longstanding barrier to progress in psychiatry, both in the context of clinical settings and drug trials, has been the fundamental difficulty of accurately measuring mood states, behaviors, and social functioning of individuals affected by mood disorders. The main objective of this proposal is to develop new analytical tools and technology capable of integrating active and passive data streams, collected from subjects using a smartphone application, in order to create a set of novel behavioral metrics. These metrics will provide low-cost, highly scalable tools for monitoring social functioning and behavioral patterns of participants, holding promise not only as a research technique but also as an instrument for collecting outcome data.